Factor XII Inhibitor for Surface Initiated Thrombosis

Project Summary
Certain life-saving interventions such as cardiopulmonary bypass (CPB), extracorporeal membrane
oxygenation (ECMO), hemodialysis, or ventricular assist device (VAD) pumps require the use of heparin to
maintain blood flow through the devices and/or to prevent downstream thromboembolic complications. Several
other invasive vascular procedures also utilize temporal anticoagulation, such as during and after prosthetic
vascular graft implantation. Unfortunately, antithrombotic agents such as heparin inadvertently target vital
hemostatic molecular mechanisms and can have severe dose-limiting hemorrhagic toxicity. Consequently, the
level of anticoagulation must be limited to balance the risk of bleeding with that of thrombosis. As a result,
device failure and thrombotic complications can be frequent and devastating. Our recent studies suggest that
coagulation factor XII (FXII) contributes to the progression of thrombosis, and thereby is a potential target for a
new class of antithrombotic drugs. Since data also suggests that FXII does not contribute to hemostasis, and
FXII deficiency is an asymptomatic condition in mammals, FXII inhibition is unlikely to have significant adverse
effects. In this Phase IIB Small Market project, we will continue to develop our innovative anticoagulant drug
candidate for use during ECMO and other thrombotic indications with a high bleeding risk. We are currently on
track to reach all of our Phase I/II Fast-Track milestones by the beginning of Phase IIB and have: 1) confirmed
that targeting FXII in our ECMO model is antithrombotic and improves the effectiveness of heparin without a
detectable increase in hemostasis impairment, 2) humanized our lead murine anti-FXII antibody, which is now
designated as AB054, and 3) completed development of a stable manufacturing cell line that is being used to
produce a toxicology lot of AB054. We have also developed IND-enabling GLP toxicity protocols for studies
that will commence at Charles River Labs (Reno, NV) upon release of our toxicology lot at the start of Phase
IIB. This Small Market project, combined with our secured matching funds, will provide essential support for
continued product development towards an IND application and clinical trials for the ECMO indication. Our
specific aims are to: 1) determine the toxicity of the humanized anti-FXII antibody, AB054, 2) manufacture a
cGMP lot of AB054 for human studies, and 3) initiate a phase 1 clinical trial to evaluate the safety, tolerability,
pharmacokinetics, and pharmacodynamics of AB054. Success of this project will propel AB054 towards a
phase 2 human proof-of-concept clinical trial in our proposed initial small market entry indication: safe
anticoagulation during ECMO, where heparin can cause bleeding and often fails to sustain device perfusion.

Public health relevance
Project Narrative The blood-thinner heparin has long been used to prevent blood clot formation during certain life-saving procedures such as extracorporeal membrane blood oxygenation in patients whose lungs fail or cardiopulmonary bypass during open-heart surgeries, but heparin has severe bleeding side effects and is often not fully effective. Consequently, there remains an urgent unmet medical need for improving the safety and effectiveness of anticoagulation during interventional vascular procedures. The proposed research addresses this need by continuing the development of a new anticoagulant antibody drug candidate, AB054, which does not affect hemostasis (bleeding control), but has antithrombotic effects, and therefore could be used alone or to improve the safety and effectiveness of heparinization.